Statistical Methods for Confocal Microscopy Images of Microglia

Project Summary/Abstract
Microglia are immune cells that act as the primary rst-responding sentinels in the brain. In response to brain
injury, infection, or disease, microglia rapidly react to attack intruders, remove neuronal debris, and restore home-
ostasis. In addition to their immune role, microglia have been shown to be critical to normal brain development
and function. Although direct comparisons between morphology and function are hard to make, it is clear that
changes in microglial morphology correspond to di erent responses to external stimuli and internal functional
states. Reactive microglia undergo a series of stereotyped morphological changes that grossly correspond to their
di erent immune functions. Additionally, it has been shown that microglial morphology is altered with neuronal
activity, demonstrating that changes in their physiological functions are tied to distinct morphologies, even in the
absence of pathology. Analysis of alterations in microglial morphology can inform studies of neurodevelopment,
neurodegenerative diseases, and the e ects of environmental toxicants on brain function; however, currently we
are unable to ascribed speci c functions to morphological states. Improved methods of processing and analysis
have the potential to remove this critical barrier and allow us to directly link morphological changes with their
corresponding functional consequences.
Confocal microscopy is used to capture digital images at the spatial resolution necessary to detect the morphol-
ogy of individual microglia. These images are often processed using proprietary commercial software to extract
individual cells. The morphology of these cells is then quantifying using Sholl Analysis, in which concentric circles
are overlaid on the image and the number of microglial branches that intersect the circle at each distance from
the soma are counted. The resulting curves are subsequently analyzed to obtain summary statistics, such as the
maximum number of intersections observed. The majority of these summaries ignore the dependence between
adjacent distances and lack a corresponding measure of uncertainty. Furthermore, current methods discard a
vast amount of information present in both the Sholl curves and, to an even greater degree, in the digital images
themselves. Finally, individual quantitative summaries are typically analyzed separately, ignoring the dependence
between di erent aspects of microglial morphology and thereby reducing statistical power.
We propose to develop statistical methods to model microglial morphology that fully leverage the wealth
of information present in the imaging data and provide interpretable parameter estimates and corresponding
measures of uncertainty. The overall goal of the proposed research is to develop statistical methodology that will
lead to improved analysis of microglial images and uncover the changes in morphology that are most predictive of
alterations in microglial function.

Public health relevance
Project Narrative Microglia are immune cells that act as the primary rst-responding sentinels in the brain. Although direct comparisons between microglia morphology and function are hard to make, it is clear that morphology changes in response to many diseases. Improved methods of microglia image processing and analysis are needed to directly link morphological changes with their corresponding functional consequences in models of many human disease processes.